Developing an innovative statistical framework to integrate multiple verbal autopsy datasets to estimate cause-specific mortality

Project Abstract
Cause of death data are essential for understanding the burden of disease, emerging health needs, and the
effectiveness of public health interventions. Few low- and middle-income countries (LMIC) have adequate vital
statistics systems that produce high quality statistics on causes of death. Verbal autopsy (VA) is a widely adopted
tool to collect information on causes of death when full autopsy and death certiﬁcation are not possible. The
current analytical methods for VA are signiﬁcantly limited by the lack of generalizability. Existing VA methods yield
inaccurate cause-of-death assignment and biased estimates of the distribution of deaths when they are deployed
to populations that are different than the populations based on which the models are developed. In this project,
we will develop robust, domain adaptive, and computationally feasible methods to assign causes to individual
deaths and estimate cause-speciﬁc mortality, by completing the following aims: (i) to develop statistical models
to characterize multiple heterogeneous VA datasets; (ii) to develop and evaluate domain adaptive algorithms
for cause-of-death assignment in new populations; and (iii) to extend the uniﬁed domain adaptation framework
to routine VA analysis pipeline. This new framework will improve on existing VA methods by utilizing the full
information available in reference deaths from multiple populations to achieve robustness to data shift across
populations. The framework will also incorporate the complex dependence relationship in the collected signs and
symptoms in an interpretable manner, and allow fast and streamlined implementation compatible with standard
VA questionnaires. We will develop the ﬁrst uniﬁed framework for domain adaptive cause-of-death assignment
using VA data and offer critical insights into the relationship between the signs and symptoms collected by VA and
causes of death. The project will lay the groundwork for future research, such as integrating VAs with additional
covariates and biomarker information collected from medical history or tissue samples, and designing systematic
cause-of-death monitoring and surveillance using large-scale VA surveys.

Public health relevance
Project Narrative In most low and middle-income countries, there are limited data on causes of death. This project develops new methods for understanding the distribution of causes of death in populations that do not have traditional vital statistics systems. The results of this project will help to develop an improved system for better understanding important causes of death as well as ways to better target and evaluate interventions to prevent death.